Understanding how alcohol use affects adolescent COVID-19 acquisition and disease course overtime

One in six 14-17 year-olds (16.3%) have tested positive for COVID-19. Understanding the factors that confer increased risk is imperative given adolescents’ vulnerable developmental stage. One particularly salient risk factor may be alcohol use, both because intense alcohol use negatively impacts immune system functioning and sleep patterns, and also because consuming alcohol with others could lead to lowered inhibitions that result in reduced social distancing. COVID-19 also may be impacting the way in which adolescents consume alcohol, potentially with life-long consequences. Understanding how pandemic experiences have affected the frequency and intensity of alcohol use is necessary for ensuring sufficient treatment supports for youth. It also is crucial to know how alcohol may affect the COVID-19 disease course, including the severity and long-term impact on somatic and mental health.
The pandemic also has reified long-standing health inequities. Indeed, data overwhelming suggest that Black/African American and Hispanic people are significantly more likely to acquire COVID-19, and to have a worse disease course. The same is true for people who identify as a sexual and gender minority (SGM). Before the pandemic, high school-aged SGM youth reported higher rates of alcohol use than non-SGM youth, whereas rates were similar for Hispanic and White youth and significantly lower for Black/African American youth. Ensuring that we understand how pandemic experiences and alcohol together may be conferring risk similarly and differently for these minority adolescent populations is fundamental to addressing disparities.
In response to RFA-AA-21-002, we propose to recruit and survey ~1,700 14-18 year-olds, ~300 of whom will have tested positive for COVID-19 in the past 3 months and ~1,400 of whom will have either never tested positive for COVID-19 or tested positive more than 3 months ago. Using procedures successfully implemented by the research team previously, adolescents will be recruited on social media and surveyed online. This will afford a national scope while empowering youth to engage in this sensitive survey topic where and when it is safe for them. Youth who have tested positive for COVID-19 at baseline will be asked to retrospectively report their disease severity, progression, and outcomes, as well as their current COVID-19-related symptoms. All youth will provide information about their past and current alcohol use, as well as past and current COVID-protective and -risk behaviors. All youth then will be prospectively followed for 24 months. They will complete comprehensive online surveys at 6-, 12-, 18- and 24-months, and brief, monthly surveys that query the key exposures and outcomes in the in-between months in the first 12 months; and quarterly (i.e., at month 15 and 21) in the second 12 months. Our main exposures will be 1) alcohol use in the past 30 days, 2) binge drinking in the past 30 days, and 3) alcohol use disorder. Our main outcome measures will be: 1) COVID-19 acquisition; 2) the extent of and 3) length to which symptoms are experienced.
Findings will have both short- and long-term impact on the public health response to this and future pandemics.

Public health relevance
Although adolescents overall tend to present with less severe symptoms with COVID-19, the intersection of this disease with co-related health risk behaviors, like alcohol use, could have a profound life course impact. This proposal will make significant contributions to inform the public health response in real-time by a) investigating the ways in which alcohol confers risk for COVID-19 acquisition for adolescents; b) whether, and if so, how, alcohol affects the COVID-19 disease course for young people, c) how the pandemic experience is impacting adolescent alcohol use consumption, particularly how it changes as we continue to move through different stages of the pandemic, and d) how these findings are similar and different for sexual, gender, racial and ethnic minority youth, who have been disproportionately impacted by the pandemic. The study will have long-term impact by helping to inform the response to future public health crises, particularly with regards to needed supports for adolescents.